MECHANISMS OF DESMOSOME REGULATION IN SKIN DISEASE

Desmosomes are adhesive intercellular junctions that play critical roles in epidermal
homeostasis by mediating robust cell-cell adhesion and by modulating signaling pathways that
regulate epidermal differentiation. The importance of desmosomes is highlighted by numerous
autoimmune and inherited skin diseases that compromise desmosome function and cause epidermal
fragility. These diseases include pemphigus vulgaris (PV), a severe autoimmune epidermal blistering
disease caused by autoantibodies (IgG) directed against the desmosomal cadherin desmoglein-3
(Dsg3), and severe dermatitis, multiple allergies and metabolic wasting (SAM) syndrome caused by
DSG1 loss of function mutations. Our previous studies of PV revealed that desmosomal proteins are
associated with lipid rafts, and our recent findings indicate that a mutation in the Dsg1TMD that
abrogates lipid raft association, compromises desmosome formation, and causes SAM syndrome.
Lipid rafts are important for a variety of cellular functions, including signaling, endocytosis and
membrane domain formation. The important role of lipid rafts in regulating Dsg function in different
skin diseases underscores the importance of Dsg association with lipid rafts in normal desmosome
function and epidermal homeostasis. We hypothesize that Dsg association with rafts is required for
desmosome assembly, segregation from adherens junctions, and for Dsg adhesive and signaling
activities necessary for epidermal homeostasis. The experiments outlined in this proposal are
designed to reveal the raft targeting features of desmosomal cadherins, how raft association
regulates desmosome and adherens junction membrane domain formation, and how loss of Dsg raft
association leads to SAM syndrome. The outcome of these studies will produce fundamentally new
conceptual models for desmosome regulation and will form a foundation for the treatment of skin
diseases associated with loss of desmosome function.

Public health relevance
These studies are designed to generate new insights into the basic cellular mechanisms that regulate cell-cell interactions, and to expose new therapeutic targets for the treatment of pemphigus and other skin diseases characterized by skin fragility.